Tumor Biology Research Program

PROJECT SUMMARY: TUMOR BIOLOGY RESEARCH PROGRAM
The Sylvester Comprehensive Cancer Center (Sylvester) Tumor Biology (TB) Research Program, led by Scott
Welford, PhD, and Priyamvada Rai, PhD, is composed of 36 members in ten departments. The TB program
fosters collaborative, primarily basic mechanistic cancer research, related to Sylvester’s high-priority cancers
and the unmet needs of its four-county catchment area (CA). Over the current reporting period (6/1/2018-
5/31/23), Sylvester has provided significant support for TB program development, including funds for faculty
recruitment, pilot grants, and acquisition of key resources to support transdisciplinary, translational, and team
science. TB members have expertise in studying cancer cells and the tumor microenvironment (TME),
including the signaling pathways that regulate biological stress responses, redox homeostasis, immune
modulation, and inflammation. The program’s primary mission is to understand how tumors arise and progress
and uncover mechanisms underlying chemotherapeutic resistance. To accomplish these goals, TB members
have prioritized three scientific aims, to: 1) elucidate mechanisms underlying tumor initiation; 2) investigate the
underpinnings of tumor progression and drug resistance; and 3) identify and characterize molecular
vulnerabilities in cancer.
The TB program holds a current research funding portfolio of $9.4M in direct peer-reviewed funding, including
$5.1M from the NCI. Since the initial CCSG submission in 2018, program members have published 489 peer-
reviewed, cancer-relevant papers: 23% were intra-programmatic and 30% were inter-programmatic (vs. 21%
and 18%, respectively, in the 2018 submission), 32% were in journals with impact factors ≥10 (vs. 19% in the
2018 submission), and 67% involved collaborations with external institutions. TB members lead four training
grants (three T32s, including renewal of the T32 Research Training Program in Surgical Oncology in 2021, and
one R25). Expertise and services provided by all six Sylvester Shared Resources support TB members’
research. Recent achievements include the discovery of novel roles of both redox response mechanisms and
protein adducts in activating oncogenic transcription networks, which led to a successful NCI P01 grant to
study esophageal adenocarcinoma. Other notable achievements include the identification of AVPR1A, a G
protein-coupled receptor target in castration-resistant prostate cancer, and obesity-induced signaling by the
adipokine chemerin in renal cell cancer development. To advance translational and bench-to-bedside
research, TB members collaborate with colleagues in the Translational and Clinical Oncology (TCO) Research
Program to advance clinical trial development. Thus, TB is a basic science program that capitalizes on
Sylvester’s infrastructure, resources, and environment to advance collaborative, innovative, and CA-relevant
basic research in alignment with the Sylvester 2019-2023 Strategic Plan.